Technology Development Coordinating Center

PROJECT SUMMARY/ABSTRACT
The NHGRI Genome Technology Program (GTP) encompasses a substantial breadth of scientific approaches and objectives, from instrumentation development to high-throughput application of technologies for characterizing the genomic basis for phenotypic traits. These research efforts have produced significant insight into biology and disease, and yet there are many opportunities to accelerate innovation, development, and early dissemination of genomic technologies. The goal of the Technology Development Coordinating Center (TDCC) is to maximize these opportunities by promoting interaction among grantees, supporting innovative new ideas through pilot funding, and aiding in the dissemination of research results and new technologies to the broader scientific community. The TDCC will focus on three primary areas, aligned with these goals: 1) Support information exchange across the GTP leading to cross-fertilization of ideas. We will build on established Scientific Working Groups (SWG) that provide a venue for discussion of work in progress and collaboration on areas of shared interested and by hosting the annual program meeting Advances in Genomic Technology Development (AGTD). We will also work with the Centers of Excellence in Genomic Science (CEGS) each year to host the annual CEGS program meeting, providing logistical support and programmatic continuity, while encouraging evolution of the format based on the location and host priorities. We will use the SWGs to identify gaps in the field that will provide the foundation for solicitation of Opportunity Funds. 2) Establish and manage an Opportunity Funds program to support initial development of promising new technologies and ideas or to enhance dissemination of new technologies. Peer review will be conducted by an External Review Panel of experts representing the breadth of fields of the GTP. 3) Implement outreach activities to improve awareness of GTP successes and facilitate access to GTP research by the broader scientific community. Outreach activities will be a combination of online/webinar format, focused video productions, and in-person meetings that incorporate interactive components. We will incorporate input on content and format from other NIH programs. A concerted effort will be made to promote TDCC outreach activities to a broad group of researchers who may benefit from information about new technologies from the GTP and their applications. The annual and SWG meetings will provide opportunities for trainee engagement and contribution. Leveraging the experience of the large number of SBIR award recipients who are TDCC participants, we will focus on issues related to commercialization of new technologies providing researchers with information and perspective on how to expand access to new methods beyond the developers’ labs. The Jackson Laboratory (JAX) is well qualified to serve as the TDCC, bringing together broad expertise in genomics, extensive experience in consortium management and conference development, and established relationships with NHGRI grantees.

Public health relevance
PROJECT NARRATIVE The NHGRI Genome Technology Program (GTP) supports innovation, development, and early dissemination of genomic technologies. The Technology Development Coordinating Center (TDCC) serves as a hub for collaboration and communication among GTP grantees and the wider NHGRI-supported community to accelerate technology development. Toward this aim, the TDCC will pursue three over-arching objectives: 1) coordinate interactions among NHGRI GTP grantees to enhance communication and collaboration, 2) manage an Opportunity Funds program to promote early-stage development of innovative technologies, and 3) facilitate outreach via promotion of grantee research to a broad scientific community.